Role of interneurons in resting state fMRI connectivity during normal development and after perinatal brain injury

Despite improvements of neonatal intensive care over recent decades, hypoxic-ischemic perinatal brain
injury remains a major cause of neurodevelopmental impairment among term and preterm infant, including
motor, behavioral and cognitive deficits. Diagnosis of cognitive and behavioral abnormalities cannot be
accurately made until 2-3 years old. Current state of the art provides no objective functional measures of brain
injury in newborns that predict long term cognitive and behavioral deficits. Clearly there is a need for an early
non-invasive measure that can prognosticate for cognitive problems in later development and provide an
opportunity for early intervention.
Among few available modalities to assess functional brain development is resting state functional MRI
(rsfMRI). This modality is particularly suited for neonatal and infant studies since it requires minimal subject
cooperation, easy to implement, short in duration, and can be done in natural sleep. However, mechanism and
origins of rsfMRI signal are poorly understood. Emerging cellular mechanisms of microvascular tone regulation
and our preliminary observations suggest that activity of GABAergic interneurons, and not primary neurons,
may play a significant role in early local rsfMRI connectivity. Developmental shift to higher frequencies and
increased amplitudes of rsfMRI BOLD oscillations in this range coincides with the maturation of interneurons in
somatosensory cortexes in early perinatal period. We hypothesized that properties of rsfMRI signal in the
higher range of rsfMRI and local rsfMRI connectivity is largely determined by activity of interneurons and thus
reflect maturation progression of cortical interneurons during normal perinatal development and after injury.
The overall goals of the proposal are to explore cellular mechanisms of rsfMRI regulation, discover and
validate cell specific information in rsfMRI connectivity that informs us about the state of functional maturation
of cortical interneurons in early postnatal period in rabbit. Using simultaneous recording of neuronal activity,
local tissue oxygen fluctuations during MRI acquisition in Aim 1 we will characterize physiological mechanisms
modulating resting state fMRI signal in rabbit cortex during postnatal development. Role of interneurons will be
explored using pharmacological interventions to selectively block activity of interneurons and and/or pyramidal
neurons. Specific signature of interneuron contribution to rsfMRI signal and local connectivity between
neighboring voxels will be determined during normal postnatal development and applied to predict injury to
interneurons and cognitive abnormalities in Aim 2 in a rabbit model of antenatal hypoxic ischemic injury.

Public health relevance
This goal of the study is to elucidate basic mechanisms of resting state functional MRI regulation and the role of interneurons during postnatal development in rabbits. As a result we expect to develop a specific early MRI marker to detect interneuron injury after perinatal hypoxia-ischemia prognostic of behavioral and cognitive impairments.